ACTG 226 ORAL GANCICLOVIR IN HIV INFECTED CHILDREN WITH CYTOMEGALOVIRUS INFECTION

Phase I/II study to determine the metabolism, maximum tolerated dose and long-term safety of oral ganciclovir in HIV-infected children with CMV infection or quiescent cmv disease.